Core-003

The University of Cincinnati’s Center for Clinical and Translational Science and Training (CCTST) is dedicated
to providing all current and future members of the clinical and translational science workforce within our
institution, community, and beyond with state-of-the-science educational opportunities. To accomplish this
endeavor, we propose to further develop our Translational Workforce Development (TWD) program to
provide training for early-stage, mid-career, and established investigators; boots-on-the-ground clinical
research professionals; pre-professional trainees (allied health, pre-medical, nursing, dental, and medical
assistants); and innovatively, community residents and high school students. Specifically, we will: 1) create
new opportunities for formal training in community-engaged research for health equity, translational regulatory
science, and acute care research; 2) develop a comprehensive training program for clinical research
professionals to enhance the clinical research workforce, emphasizing a team-based approach; 3) expand and
diversify the pipeline of translational researchers by exposing early-stage students (high school, allied health
associate students, undergraduate health professions) to clinical research using existing and proposed
community-engaged programs; and 4) design training for high-quality clinical data management and
dissemination. To further support the workforce and development of translational research initiatives, the Pilot
Translational and Clinical Studies Program (PTC) provides the means for junior and established basic
science and clinical investigators to engage in multidisciplinary and collaborative team science approaches,
develop efficient methods and processes, and generate robust preliminary data necessary for large-scale
funding opportunities. The overall goal of the PTC is to accelerate the development of novel disease
biomarkers, diagnostic tests, and therapies by facilitating translation of basic science laboratory discoveries
across the Academic Health Center into novel clinical approaches and interventions. To build on the PTC’s
success, we will innovatively expand the program by facilitating novel pilot translational and clinical studies
through promotion of interdisciplinary and community collaboration and provide mechanisms for junior faculty
to increase independence by providing active investigator assistance and a robust portfolio of pilot project
mechanisms. Specifically, we will: 1) provide a comprehensive pilot project portfolio, including team-based and
community-engaged support programs and resources, to promote collaboration and catalyze advancement of
science across the translational research continuum throughout the Academic Health Center and beyond; and
2) develop training opportunities and resources for junior investigators to promote independence in clinical and
translational research.